MOLECULAR MODEL OF AN ACTIN FILAMENT CAPPED BY SEVERING PROTEIN

Gelsolin is a six-domain protein with a wide array of actin-regulating activities. Despite the growing body of structural data on this protein, little is known about how it binds F-actin during severing and capping. We have combined data from X-ray crystallography, NMR, and electron microscopy to develop a model of an actin filament capped by a severing protein. The protein which we have modeled is G1/aA1-2, a genetically engineered molecule containing domains from both gelsolin and a-actinin. In the capped filament, domains G1 and aA1-2 of the hybrid severing protein bind two adjacent monomers along the long pitch F-actin helix. The distance spanning these domains suggests the need for a flexible linker between them. By analogy, this implies that the gelsolin deletion mutant G1-3 contacts the same two monomers in the capped filament and suggests that the linker between G1 and G2 plays a crucial role in severing and capping.